Annual meeting of the American Society for Rickettsiology

Abstract
The American Society for Rickettsiology (ASR) is the primary society for scientists studying Rickettsiales,
obligate intracellular bacteria that are significant cause of morbidity and mortality world-wide. The 33rd Meeting
of the American Society for Rickettsiology (ASR) will be held July 13-16, 2024, in Williamsburg, Virginia, with
the 34th meeting to be held in 2026 at a location to be determined. In addition to the 2024 and 2026 meetings,
ASR will participate in the 2025 International Conference on Rickettsia and Rickettsial Diseases in Lograno,
Spain, by sponsoring an oral session and travel awards for trainees and young investigators. The annual
meetings of the ASR aim to 1) provide the highest-quality scientific program to attract outstanding researchers
in academic, governmental, and private sectors; 2) promote scientific opportunities for trainees and early
career investigators to present and discuss their work in a collegial, yet scientifically rigorous environment; and
3) promote and highlight diversity, equity, and inclusivity in the field of Rickettsiology. The 33rd and 34th
meetings will feature a balance of oral presentations from established/junior investigators and trainees,
intermingled with posters from submitted abstracts. To increase cross-disciplinary research, oral sessions will
feature a Plenary Lecture from an accomplished investigator outside the field of rickettsia. Members of the
ASR Scientific Committee and Ambassadors for Diversity, Equity and Inclusion will select oral (short)
presentations based on: (i) the quality and originality of the research; and (ii) speakers in universities and
states that have been previously underrepresented at ASR meetings. In all activities, we will emphasize
visibility and inclusion of women, minorities, non-binary, and persons with disabilities, and provide networking
opportunities and promote the visibility of students, postdoctoral fellows, early career faculty. Mailings, e-
posters, and social media advertisement will highlight the availability of travel awards for attendees from
traditionally underrepresented groups and first-generation students. A website will feature the schedule,
information and registration materials for the meeting, and the ASR will make childcare/family financial support
available to participants. Williamsburg Resort offers summer camps for children, family support services and
disability access to hotel guests. Approximately two hundred attendees representing early career investigators,
mid-career scientists, established researchers, and clinicians from academia, government, and private-sector
laboratories are anticipated to attend. There is no equivalent meeting that focuses exclusively on rickettsial
diseases in the United States of America.

Public health relevance
Project Narrative The Annual Meeting of the American Society for Rickettsiology assembles clinicians, researchers, and public health scientists whose interests center on Rickettsia bacteria, a significant cause of human disease, to drive collaborative multidisciplinary research in a diverse, equitable, respectful and inclusive scientific environment.